Cell Subtype Mechanisms Underlying Stress Susceptibility and Resilence

Project Summary:
Stress alters the structure and function of brain reward circuitry leading to disruption of reward and
motivation. Stress can be a major risk factor or trigger episodes of psychiatric disorders, which encompass
altered motivational behavior; including major depressive disorder, bipolar disorder, schizophrenia, and post
traumatic stress disorder. Current studies emphasize a need to approach psychiatric diseases from a combined
circuit and molecular perspective to link candidate molecules to dysfunctional cell subtypes. Our previous work
provided an initial foundation for understanding nucleus accumbens, a major brain reward region, medium spiny
neuron (MSN) subtypes in response to stress. However, there is a critical need for a comprehensive
understanding that encompasses intrinsic molecular regulators of these MSN subtype adaptations and the
extrinsic regulators (such as microglia) that help to shape these structural adaptations in mice susceptible to
stress, as well as those displaying resilient response to stress. In this proposal we will completely characterize
structural adaptations in D1-MSN subpopulations, microglia, and the interaction between the two in stress
susceptible and resilient conditions of both sexes using chronic social defeat stress (CSDS) and chronic witness
defeat stress (CWDS) paradigms. We will manipulate microglia and D1-MSN subpopulations to determine how
these alterations affect the other cell type, D1-MSN circuit activity, and ultimately stress vulnerable or resilient
behavior including reward value behaviors. Finally, using cell subtype RNA-seq we will determine how microglia
impact stress mediated molecular adaptations in D1-MSN subtype populations and how D1-MSNs impact stress
mediated microglia adaptations. Collectively our studies can provide improved understanding of NAc cell subtype
mechanisms in susceptible and resilient subjects. Our studies could uncover future therapeutic avenues aimed
at mimicking stress resilient mechanisms or combating stress susceptible mechanisms in psychiatric
motivational symptoms

Public health relevance
Project Narrative: We propose to study the molecular and cellular mechanisms underlying stress susceptibility and resilience. We will examine adaptations in key brain reward neuronal and non-neuronal cells in social stress and the impact on reward behaviors. Our studies will provide new information into the neuronal and non-neuronal cell types in key a reward brain region in social stress, which can impact our understanding of many psychiatric illnesses affecting reward and motivation.